Midwest Consortium for Hazardous Waste Worker Training

PROJECT SUMMARY/ABSTRACT
The Midwest Consortium for Hazardous Waste Worker Training (MWC) provides model training programs
to workers and residents who may be exposed to hazardous substances. This programming is delivered by 13
training centers in 9 states: Illinois, Indiana, Kentucky, Michigan, Minnesota, North Dakota, Ohio, Tennessee,
and Wisconsin. Eight of the centers are equipment-based centers that focus most strongly on HAZWOPER
and related training for workers at designated hazardous waste sites; treatment, storage, and disposal
facilities; and in a broad range of emergency response roles. The five remaining centers are community-based
centers that focus on helping workers and residents, particularly those from disadvantaged populations, to
recognize and react to hazardous materials in their communities. From 2020 to 2024, MWC training centers
provided 3,333 programs to 50,850 trainees for 422,347 contact hours, demonstrating the impressive reach of
the Consortium, even through the challenges posed by the COVID-19 pandemic.
The long-term goal of the MWC is to improve occupational and environmental health and safety practices
throughout the region it serves. In the shorter-term, the MWC's objective is to build capacity for workers to
improve health and safety practices at their workplaces and for communities of workers and residents to
recognize, prepare for, and recover from environmental exposures. To achieve this objective, the overall aims
for the MWC are to facilitate delivery of model training programs at MWC training centers, enable training of
participants who are underserved by workplace and community hazard programming, and modernize and
simplify training program evaluation, providing greater insight into impacts of training. Achieving these aims will
allow the MWC to continue to incorporate innovative training strategies and tactics into programming and to
meet emerging needs such as to develop and deliver training on individual, workplace, and community
resilience.
The experienced, creative, and dedicated trainers at MWC centers have successfully trained hundreds of
thousands of workers since 1987, increasing the collective training output over time and demonstrating
impressive impacts. The centers provide training to workers at industrial sites, government agencies, tribal
nations, healthcare systems, and elsewhere and to residents affiliated with faith-based groups, non-profit and
community organizations, and neighborhood associations. Reported impacts of training demonstrate significant
benefits to public health, particularly in the prevention and control of hazardous substances. Participants
indicate that they learn how to act more safely and return to their workplaces and communities after training
with a motivation to implement new procedures so that fundamental change will occur. From 2025 to 2030,
MWC training centers will collectively provide 5,055 programs to 93,602 trainees during 841,366 contact hours.

Public health relevance
PROJECT NARRATIVE The Midwest Consortium for Hazardous Waste Worker Training facilitates adult-based, action-oriented, results-centered worker and community training with the goal that participants will better recognize and avoid or control risks of occupational and environmental exposure to hazardous materials and waste in nine states: Illinois, Indiana, Kentucky, Michigan, Minnesota, North Dakota, Ohio, Tennessee, and Wisconsin. While all activities are performed under a cooperative agreement with the National Institute of Environmental Health Sciences, the training also leverages the resources of U.S. government agencies including the Environmental Protection Agency, Occupational Safety and Health Administration, Department of Homeland Security, National Institute for Occupational Safety and Health, Agency for Toxic Substances and Disease Registry, Department of Transportation, Chemical Safety and Hazard Investigation Board, and Substance Abuse and Mental Health Services Administration. Midwest Consortium training centers include labor-affiliated programs, three major universities, two community colleges, an historically black university, an affiliate of a national youth training organization, a tribal nation, and several other community-based organizations, all of which form partnerships locally and regionally to build capacity among trainees to recognize and react to hazardous substances in their workplaces and communities.